Sex Effects for Hearing Loss Drug Therapies

Age-related hearing loss (ARHL), also known as presbycusis, is the predominant sensory disorder and
neurodegenerative condition of our aged population. Like many other body systems, hearing and its associated
structures decline with age, with most people experiencing some form of hearing loss by the age 60. ARHL is
gradual deterioration of auditory sensitivity, speech perception and binaural processing with age. There are
both health and social implications associated with ARHL as it has been related to other health problems, such
as an increased risk for dementia, depression, distress, and loneliness. It also decreases ability of our elderly
to live independently and increases their reliance on family and/or community support. There is no way to
prevent or reverse ARHL, and currently, there is no FDA-approved drugs to prevent or treat sensorineural
hearing loss. Most pre-clinical studies carried out so far have targeted one pathway. Here, I propose to
investigate a therapy that can target various pathways simultaneously. Specifically, the therapeutic potential of
L-ergothioneine will be investigated. Ergothioneine is a naturally occurring “super-antioxidant/anti-
inflammatory” that has intrigued many researchers since the discovery of its specific receptor OCTN1 in the
human body in 2005. It accumulates in various parts of the body depending upon its receptor expression
levels. It exists in tautomer equilibrium (thiol and thione forms), with the thione form favored at physiological
pH. Furthermore, its high redox potential (-0.06 V vs -0.2 to -0.32 V for other antioxidant thiols like glutathione)
and high safety profile (NAOEL = 800 mg/kg/day) makes it a stable and effective antioxidant. We anticipate
that it will also help in mitigating some of the key aspects of age-related hearing loss as well, since it is also an
anti-apoptotic. We have produced some exciting preliminary results – protective effects on auditory brainstem
response thresholds and on distortion product otoacoustic emission thresholds & amplitudes for aging
CBA/CaJ male mice (~25 months old, 6-month longitudinal study) but not for females These preliminary
results are novel and groundbreaking as no previous reports are available about EGT beneficial effects on the
aging auditory system. In the present proposal, we will further develop the treatment paradigm of EGT in
females by applying EGT therapies at different time points (pre, peri and post-menopausal) during the
menopause transition with the hypothesis that there is a “golden-window” during this phase where
ergothioneine will be beneficial for the females. This grant will help us to generate more initial results for pre-
clinical treatment paradigms of ergothioneine to treat hearing loss. Note that EGT has a very safe and is
readily available for human use, hence, if successful, our new findings will be rapidly translatable to the clinic.

Public health relevance
Age-related Hearing Loss (ARHL-presbycusis) is one of the two most common type of hearing impairment in the US and worldwide; and understanding sex differences in the aging auditory system and responsiveness to therapies is quite significant clinically. ARHL involves multiple co-morbidities, including declines in auditory sensitivity, presence of tinnitus (ringing in the ears), and deficits of speech understanding in background noise, but most importantly for this grant, hormones or other sex differences may affect these perceptual deficits. The thematic focus of this proposal is development of new interventions for ARHL that are effective for both sexes, through a novel examination of age changes in the auditory system that differ for females and males, in proven animal models.